A Mitochondrial Longevity Pathway: P66Shc Mechanisms

DESCRIPTION (provided by applicant): A mitochondrial longevity pathway: p66Shc mechanisms The long-term objective of this application is to understand how deficiency of the p66Shc protein extends lifespan by >30% in mice, using an interdisciplinary approach that integrates levels of biological organization progressing from biochemical, molecular, organellar, cellular, bioenergetic, pathological, and to the whole organism level. As background, genetic deficiencies in the IGF-lnsR axis have been demonstrated to extend lifespan in flies, worms, and mice;5 of 6 known lifespan-extension mutations in mice are in the IGF-lnsR pathway. The sixth mutation, in p66Shc, causes a modest decrease in size that is focused on adipose tissue, and thus less severe than in other models;preliminary data show transcripts of the IGF-lnsR axis modified in p66Shc-deficient tissues. P66Shc has a redox activity that is essential for its biological functions, including generation of reactive oxygen species (ROS), apoptosis, adipogenesis, and angiogenesis. P66Shc functions in both mitochondrial and cytoplasmic compartments, and it interacts directly with components of the mitochondrial respiratory chain. Therefore, we will elucidate the physiological functions of p66Shc and the mechanism by which deficiencies of these functions extend lifespan, by an interdisciplinary and integrative study. In Project 1, the biochemical structure, function, and partners of p66Shc will be clarified, as well as the consequences of p66Shc for metabolic syndrome (e.g., a mechanism by which adiposity leads to disease). In Project 2, the stimuli for p66Shc recruitment to the mitochondria and plasma membrane will be studied, as well as the mitochondrial consequences of p66Shc recruitment. In Project 3, microarray and proteomics will be performed, to assess the primary consequences of p66Shc deficiency in relevant cell types. And, in Project 4, the metabolic and bioenergetic underpinnings of lifespan extension by p66Shc-deficiency will be determined. Core A will support weekly meetings and continuous data flow to catalyze synergistic interactions;Core B will provide backcrossed and barrier-derived animals and expertise in mouse pathology to determine the category(ies) of morbidity retarded by p66Shc deficiency;and Core C will provide support for optimum study design and robust biostatistical analysis. Relevance to public health: The conserved nature of the IGF-lnsR axis pathway for lifespan extension worms and mice, and the impact of p66Shc on adiposity, suggests that elucidation of the p66Shc will likely be relevant to human health in the United States.